PERIPHERAL AND CARDIAC ADRENERGIC RESPONSE TO COLD STRESS

Investigate the adrenergic response to core hypothermia, and to identify any overlap or interaction between peripheral and cardiac sympathetic activation during hypothermia and rewarming.